Interspecies microbial interactions in CKD

ABSTRACT
Chronic kidney disease (CKD) is a gradual loss of kidney function, which affects an
estimated 37 million American adults, resulting in 14.6 deaths per 100,000 population. Once
kidney damage occurs, it impairs removal of uremic toxins, leading to further deterioration of
physiological functions and progression of renal failure. Surprisingly, many uremic toxins are not
produced by the body itself, but rather derived from the gut microbiota. CKD is associated with
changes in the composition of the gut microbiota (dysbiosis), which is characterized by an
increased abundance of Enterobacteriaceae in the fecal microbiota, a group of microbes known
to produce uremic toxins, such as indole. The objectives of this application are to understand the
ecological causes of dysbiosis in CKD on a molecular level and to determine whether dysbiosis
has a causative effect on CKD progression. Our central hypothesis is that elevated expression of
inducible nitric oxide synthase (iNOS) in the intestine fuels growth of Enterobacteriaceae by
anaerobic nitrate respiration. In turn, increased indole production by respiring Enterobacteriaceae
aggravates CKD disease progression. We will test different aspects of our hypothesis using the
logical and innovative approach outlined in the following specific aims. Specific Aim 1: Determine
the ecological causes of dysbiosis during CKD. Specific Aim 2: Determine whether dysbiosis has
a causative effect on CKD progression. The proposed work is innovative because it is among the
first to provide molecular insights into how changes in the microbiota composition occur in CKD,
and how microbiota changes are causatively linked to disease progression. Successful
completion of the proposed work will establish how CKD-associated host responses drive
changes in the ecology of the gut microbiota, which in turn set the stage for release of uremic
toxins by Enterobacteriaceae, thus accelerating CKD progression. This outcome will be of broad
significance for the rational design of new intervention strategies.

Public health relevance
PROJECT NARRATIVE Chronic kidney disease is a gradual loss of kidney function, which is a major cause of morbidity and mortality in the US. Once kidney damage occurs, it results in incomplete removal of toxic products made by our microflora, termed uremic toxins, which accelerates disease progression. Chronic kidney disease is linked to changes in the composition of our microflora (dysbiosis), but it remains unclear whether these compositional changes accelerate disease progression. Successful completion of the proposed research will reveal the ecological causes of dysbiosis and determine whether dysbiosis has causative effects on chronic kidney disease progression. This information will be a critical first step for translating advances in microbiome research into clinical intervention.